Career Enhancement Program (CEP)

SUMMARY: CAREER ENHANCEMENT PROGRAM
The Career Enhancement Program (CEP) is a critical component of the MD Anderson Cancer Center (MD
Anderson) Brain Cancer SPORE because it provides funding for early-stage basic scientist, physician-
scientists, and clinical trialists to develop independent careers in brain cancer research, guided by senior
mentors with outstanding track-records in translational research. The program also supports established faculty
who wish to enhance or refocus their careers on translational brain cancer research. Therefore, the CEP seeks
to:
1) Recruit and train early-stage physicians and scientists to become outstanding translational investigators in
the field of neuro-oncology.
2) Recruit established faculty who wish to enhance or refocus their careers on translational brain cancer
research
3) Provide funding for projects of early-stage investigators with the goal of obtaining the necessary preliminary
data to secure large independent research grants (e.g., R01) or to become full projects in the SPORE.
4) Provide outstanding mentorship to guide recipients to develop the intellectual, communication, organizational
and technical skills required to be productive investigators in translational brain cancer research;
5) Teach awardees basic principles of cancer biology that are not commonly included in clinical training or PhD
programs;
6) Recruit women and underrepresented groups into the program, as a special emphasis.
These objectives are achieved through a strong mentorship program in which awardees not only receive funds
for specific research proposals, but also are mentored on how to excel in translational brain cancer research.
Our CEP has successfully expanded the brain cancer research community and will continue to do so during this
renewal SPORE cycle. Of the 20 awardees in the past two cycles, 8 (40%) were women or members of minority
groups, and an impressive 60% have gone on to secure independent peer-reviewed grant funding, and to
establish impressive research careers.

Public health relevance
NARRATIVE: CAREER ENHANCEMENT PROGRAM The Career Enhancement Program (CEP) fosters the scientific development of junior investigators who intend to focus their careers on translational studies of brain tumors, and of established investigators who wish to refocus their careers on brain cancer research. The program provides funding of novel projects, and equally valuable, mentoring by senior scientists with outstanding track records. In past funding cycles, an impressive 60% of awardees have gone on to secure independent peer-reviewed grant funding, and similar results are anticipated in this renewal period. .